Name Molecular mechanisms of bacterial toxins targeting actin cytoskeleton

Project Summary/Abstract
Dissemination of multidrug-resistant pathogens has undermined the efficiency of antibiotics and urged a more
thorough understanding of bacterial pathogenicity. Bacterial pathogens developed various elegant and
sophisticated ways to disrupt and/or usurp the actin cytoskeleton, which plays vital roles in human defense
mechanisms. By hijacking the actin cytoskeleton, pathogenic toxins disturb cell morphology, cell motility,
phagocytosis, epithelial permeability, and antigen presentation. Being constantly tuned to the host cytoskeleton
by co-evolution, they recognize weaknesses in the host defense and represent powerful tools that foster the
understanding of the cytoskeleton on molecular and cellular levels. The long-term goals of the project are to
decipher molecular and cellular mechanisms of bacterial toxins targeting the actin cytoskeleton and to utilize the
obtained knowledge to illuminate functions of the actin cytoskeleton in norm and pathology.
The current proposal is directly relevant to the NIH mission as it focuses on two families of related toxins,
VopF/VopL and VopM/VopV, produced by human pathogens Vibrio cholerae and Vibrio parahaemolyticus. Both
are a common cause of seafood poisoning, while the spread of V. parahaemolyticus has rendered it a major
health threat worldwide. Both toxin families are known to affect actin, but their pathogenic mechanisms remain
poorly understood. Vop toxins are predicted to cooperate, but understanding of their synergistic effects is
impossible without an in-depth understanding of their individual mechanisms.
Research strategy: To assure scientific rigor, two toxins in each family will be characterized in parallel using
several highly complementary experimental approaches. Specifically, the effects of the toxins on actin dynamics
in bulk and at the single-filament level will be combined with cell biology approaches. Cellular targets of the toxins
will be identified by a combination of proximity labeling and mass spectrometry. In Specific Aim 1, the
methodological gap between molecular and cellular mechanisms of toxicity will be addressed by live-cell imaging
at the single-molecule level to reveal the molecular behavior of VopF/L toxins in host cells. The hypothesis will
be tested that uncontrolled multidirectional polymerization of actin by the toxins results in disruption of actin
polarity. Specific Aim 2 will reveal novel mechanisms employed by VopM/V toxins. The hypothesis will be tested
that hijacking the actin cytoskeleton by VopM/V toxins results in compromised ability of the cell to respond to
external and internal stimuli leading to compromised cell integrity. Knowledge gained in the course of the
proposal will be applied to discover currently unrecognized elements of the actin cytoskeleton involved in the
mechanical homeostasis of intestinal epithelium. The proposed study is both significant and innovative as it fills
a major gap in our understanding of pathogenic mechanisms employed by several life-threatening pathogens
and allows the research team to utilize the acquired knowledge by creating tools for deeper understanding of the
actin cytoskeleton.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to human health as it explores novel mechanisms of pathogenicity employed by two families of bacterial toxins VopF/VopL and VopM/VopV. These toxins are produced by pathogenic strains of Vibrio cholerae and Vibrio parahaemolyticus, as well as related species of bacteria. Understanding such mechanisms will help to clarify the roles of the actin machinery in defense against pathogenic microorganisms, improve our ability to treat life- threatening infectious diseases, and lead to the creation of innovative research strategies, thereby satisfying several criteria relevant to NIH’s mission.